The role of Cindr and its protein interactors in epithelial morphogenesis

PROJECT SUMMARY/ABSTRACT Our goal is to understand the molecular and cellular mechanisms that coordinate to pattern complex epithelial organs. These conserved mechanisms must be correctly regulated to generate functional organs and are frequently re-­utilized in mature organs to maintain homeostasis and function. We focus on a conserved family of core adaptor proteins that are key regulators of cell and tissue stability: Cindr (in Drosophila) and the mouse orthologs Cin85 and Cd2ap. Cindr recruits protein complexes that include actin regulators and signaling proteins. Exploring the dynamic function of these complexes ? and how they are regulated -­ will elucidate the system of molecular events that pattern tissues and how these go awry. In preliminary studies we observed functional interactions between Cindr and the Drosophila Jun terminal kinase JNK (Bsk in flies) and Cindr and Mask (a component of Hippo signaling) that are essential for correct tissue patterning. Our data supports the hypotheses that Cindr interacts with JNK/Bsk to restrict JNK (Specific Aim 1) and with Mask to promote its function and that of its cofactor Yki (Specific Aim 2) which is repressed when Hippo signaling is active. These preliminary findings have far-­reaching implications firstly because the contributions of JNK and Hippo signaling to organ morphogenesis are unclear. Second, the role of Cindr in regulating and integrating these signals during organ patterning has not been explored. To address these open questions, we will combine genetic, biochemical, immunofluorescence and live-­cell-­imaging approaches to elucidate the specific contributions of JNK and Mask and their interactions with Cindr to Drosophila eye patterning.

Public health relevance
PROJECT NARRATIVE It is essential that organs are correctly shaped and patterned during development. Our research explores the molecular signals and cell behaviors that are coordinated to generate functional organs. Many of these mechanisms are also used later to maintain organ homeostasis and function and are reactivated during organ repair or are co- opted to drive disease. Our studies focus on the function of a conserved adaptor protein family (Cindr/Cd2ap/Cin85) that is essential for epithelial organ development and function. Aberrant function of these adaptors has been implicated in metastasis, Alzheimer’s Disease and degenerative kidney diseases. Together these diseases account for close to three- quarter of a million deaths in the US each year.